Non-beta-lactam GLT-1 activators: characterization in preclinical models of opioid and cocaine addiction

PROJECT SUMMARY
No approved medications are available for cocaine abuse, and medications for opioid addiction are limited to
agonist replacement therapies that are abuse liable themselves. Glutamate is one neurochemical system that
has been recently for drug dependence and relapse. One of the most viable therapeutic targets within the
glutamate system is glutamate transporter subtype 1 (GLT-1), a predominantly astrocytic protein that clears
glutamate from the extracellular compartment in the CNS. GLT-1 transport and uptake mechanisms are
dysregulated during COC or opioid exposure and facilitate the enhanced glutamate transmission in brain
reward circuits that underlie dependence and relapse. Agents that enhance the expression of GLT-1
transporters do display efficacy in preclinical models of drug addiction and related CNS disorders, but an
existing hurdle is the disappointing clinical translation. Part of the problem is the agents themselves, which are
limited mostly to β-lactam antibiotics that suffer from a host of pharmacokinetic and pharmacodynamic issues,
including parenteral administration, poor brain penetrability, chronic dosing, adverse effects, and a slow onset
of CNS efficacy that is dependent on increased GLT-1 protein expression. In this proposal, we address both
the lack of effective treatments for cocaine and opioid addiction and the limited diversity in the GLT-1 activator
pipeline. We propose to characterize the efficacy of two non-β-lactam GLT-1 activators (e.g. troriluzole [TRLZ]
and NA-014) in rat assays that model cocaine and opioid reinforcement, dependence, and relapse. TRLZ is a
prodrug of riluzole (approved for ALS) that is already being tested in clinical trials for obsessive-compulsive
disorder and spinal cerebella. TRLZ displays a unique pharmacodynamic profile in that it acts that acts through
a dual mechanism to enhance cellular glutamate uptake and inhibit neuronal glutamate release. Despite a
glutamate-based profile that is favorable for potentially treating drug abuse, the parent drug RLZ has only been
assessed in few preclinical studies that have yielded mixed outcomes. Our interest in RLZ-like compounds for
drug addiction was recently reignited by a 2018 study showing that RLZ reduces cocaine relapse in rats. RLZ
itself, however, is an unlikely candidate for repurposing because of reduced efficacy and potency related to
pharmacokinetic limitations, including high first-pass hepatic metabolism, elevated liver enzymes, a negative
food effect, low aqueous solubility, and poor oral palatability. To mitigate limitations of RLZ, we designed,
synthesized, and evaluated TRLZ as a third-generation prodrug with optimized in vitro and in vivo features.
The second GLT-1 activator is NA-014, which directly activates GLT-1 through selective allosteric modulation
of GLT-1 after a single exposure, making it different from β-lactams that rely on upregulation of the GLT-1 but
only after repeated treatment with high doses. In summary, our results will offer the first comprehensive
information about the efficacy of non-β-lactam GLT-1 activators in preclinical models of drug addiction, and, if
positive, may pave the way for the development of safer and more effective GLT-1-based medications.

Public health relevance
PROJECT NARRATIVE Dysregulation of glutamate transporter subtype 1 (GLT-1) contributes to cocaine and opioid dependence and relapse. GLT-1 activators display efficacy in animal models of cocaine and opioid addiction, but they are limited primarily to β-lactam antibiotics that are not well tolerated by patients. By providing the first comprehensive in vivo study of GLT-1 activators that are structurally and mechanistically distinct from β-lactam antibiotics, we expect to provide an initial step in identifying non-β-lactam GLT-1 activators as potential treatments for drug addiction and related CNS diseases.